Role of epithelial cell intracellular trafficking in the innate immune response to adenovirus infection

ABSTRACT
The apical surface of polarized epithelium constitutes one of the first points of contact between the host and
pathogens such as human adenoviruses (HAdVs) that invade the lumen of the respiratory tract. In recent
years, it has become clear that respiratory epithelial cells not only serve as functional and physical barriers, but
actively contribute to the innate immune system providing initial protection against external pathogens. The
EGF receptor (EGFR), which typically exhibits basolateral polarity, has emerged as a key player in the innate
immunity of respiratory epithelium to a variety of infectious and noninfectious noxious stimuli. In contrast to the
canonical ligand-stimulated EGFR pathway, a number of cellular stresses including HAdV infection (our
studies) trigger an alternative mode of EGFR trafficking associated with sustained EGFR activity in non-
degradative endosomes. However, molecular mechanisms regulating this pathway remain poorly understood.
In addition, despite significant progress in understanding the pathological and therapeutic stresses that activate
it, relatively little is known about EGFR function in the context of cellular stress. We have recently found that
stress-induced EGFR signaling is involved in innate immune responses triggered by HAdV cell entry, as well
as following exposure to the pro-inflammatory cytokine TNF-α, in respiratory epithelial cells. Moreover, HAdV
encodes an early gene product that suppresses this pathway by promoting EGFR degradation, and which
could provide new insights to potential targets for future anti-viral therapies. Interestingly, our preliminary
studies have revealed that EGFR stress responses were tightly regulated by epithelial cell polarity, with robust
stress-induced EGFR responses only observed when receptors were mistargeted to apical membranes. In
addition, HAdV co-opted cellular pathways contributing to innate immune signaling by enabling dynamic EGFR
membrane remodeling associated with enhanced stress-induced EGFR signaling from apical membranes.
The newly described EGFR innate immune system is likely to have a central role in protecting the lung from
infection with HAdVs and perhaps other pathogens. Conversely, failure to curb this signaling network may lead
to tissue damage, respiratory compromise, and potentially systemic HAdV infections. Our research plan will
identify novel mechanisms regulating dynamic EGFR membrane remodeling in polarized epithelial cells (Aim
1), and stress-induced EGFR innate immune signaling from endosomes (Aim 2); and analyze EGFR innate
immune signaling pathways that are activated as a consequence of HAdV infection in primary human
respiratory epithelial cells and new physiological cells models with enhanced apical EGFR expression (Aim 3).
Although our studies will be carried out in the context of HAdVs, successful completion of this project will have
a broad impact on a variety of respiratory conditions in need of new therapies.

Public health relevance
PUBLIC HEALTH RELEVANCE These studies will contribute to our understanding of cellular stress responses regulated by the EGF receptor using a host-virus approach. These are fundamental processes in mammalian cells, and as such these studies will have broad medical implications. We propose that many common human disorders such as cancer and a range of inflammatory diseases employ the same cellular stress pathways as infectious agents. Our studies will therefore lead to identification of common biological pathways and new drug targets for multiple human diseases.